The wandering nerve: gateway to boost Alzheimer's disease related cognitive performance

ABSTRACT
Series of disappointing clinical trial outcomes have ushered the Alzheimer's field (AD) into an era of preventive
interventions. Researchers now recognize that AD is a continuum and that interventions should start in the
pre-symptomatic phase. To that end, transcutaneous vagus nerve stimulation (tVNS) is a promising non-
invasive approach, as its mechanisms have been attributed to the brain system that is initially affected by AD
pathology, the norepinephrine locus coeruleus (LC) system. Animal and preliminary studies in patients and
healthy individuals from our group and others demonstrated that tVNS alters locus coeruleus (LC) and nucleus
tractus solitarius (NTS) functioning and enhances memory. This indicates that tVNS targets the site of initial
AD pathology and might have the potential to delay AD-related cognitive impairment. Thus, tVNS could
address an important challenge in the field: non-invasively delaying disease progression prior to onset of
cognitive decline or significant accumulation of pathology. The overarching goal of this proposal is to apply
single and repeated tVNS in pre-symptomatic older individuals with varying degrees of AD pathology, with the
aim to determine the extent of the cognitive effects of tVNS in domains and time, and to relate tVNS outcome
to demographics, neurophysiological properties of the LC and NTS as well as burden of AD biomarkers. Our
accomplishments in optimizing tVNS and sensitive cognitive measures, ultra-high field brainstem imaging and
blood-based biomarkers allow us to examine our central hypothesis: that serial tVNS enhances memory
functioning more than single, and in particular in at-risk individuals, in whom AD pathology burden is low to
moderate and the NTS-LC system is still responsive to stimulation. To that end, 140 pre-symptomatic older
individuals (APOE-E4 enriched) will be enrolled to a double-blind randomized cross-over design of stimulation
versus sham tVNS during 7T imaging and blood sampling. This will be followed by randomized allocation to
repeated tVNS or sham for 2 weeks and a follow-up cognitive assessment after 2 months. The results of this
study will yield important information for future trials assessing tVNS in three important ways: 1) through
investigating which cognitive domains are modulated by tVNS on the short and long-term, important for
monitoring and determining outcome measures, 2) through identifying demographic characteristics, functional
brain and AD-related markers that predict beneficial responses to tVNS, which will be important to identify
trial eligibility (Aim 1 and 2) and 3) understanding biological pathways contributing to RAVANS success to
confirm target engagement, aid in biomarker stratification or enrichment of the population, and which could
serve to monitor progression (Aim 2 and 3). The research proposed is innovative because it aims to define the
target population in whom tVNS can be efficacious, based on the known underlying biological pathways of both
tVNS and AD. Refining the target population is critical as it is expected to inform eligibility criteria of large-
scale randomized clinical trials, which in turn will contribute to their success in delaying disease progression.

Public health relevance
NARRATIVE The proposed research will apply transcutaneous vagus nerve stimulation, a non-invasive brain stimulation method that modulates a system in the brain that is initially affected by Alzheimer's disease pathology and enhances memory performance, and thus may hold the key to successfully delay this disease in its earliest stages. We will assess the duration and extent of improvements in cognitive performance, and will identify individual, brain physiology and Alzheimer's disease-related factors that contribute to its success in older individuals without clinical impairment, including those at risk for Alzheimer's disease. This project has important public health implications as it gathers critical information to identify the target population, and to inform designs of future clinical trials aimed at prevention of Alzheimer's disease.